Administration and Data Management

The Administration and Data Management Core Unit (A) will provide overall scientific and administrative leadership for the ACE. An advisory system, including internal and external advisory boards will guide the progress, planning and decision-making responsibilities for the research to be conducted in each of the 4 projects, as well provide cross-project integration. The boards will be composed of the senior investigators (Internal), national leaders, professionals from the community and parents (External). Communications and integration across the scientists, trainees, community members and families will be supported by a custom-designed Research Collaboration Platform that will connect research teams, families, training materials, scheduling systems and data transfer. The Core will be responsible for handling the day-to-day administrative needs of the ACE, oversee all IRB and other regulatory obligations, and manage resource allocations. The Data Coordinating Center will be responsible for creating project databases, data collection forms, tracking systems, data manuals, data cleaning and statistical support for the research conducted in the ACE.

Public health relevance
RELEVANCE (See instructions): The multi-institutional, multi-site Center involves 4 projects focusing on a central theme, with overlapping clinical and scientific components. This complex network requires a central unit that will provide overall oversight for the administration and data management components of the planned research investigations.